Comparative Modeling for the Prevention and Control of Uterine Cancer

Uterine cancer is the 4th most common cancer in women and the 7th most frequent cause of cancer-related
death. The death rate from uterine cancer is rising faster than for any other tumor. Importantly, uterine cancer
is associated with a profound racial disparity. Compared to white women, black women are significantly more
likely to die from uterine cancer and this disparity is increasing. The overarching goal of this proposal is to
inform cancer control and prevention strategies to reduce the incidence and mortality uterine cancer by
improving the prevention, screening, and treatment of the disease. We will accomplish this goal through a
collaborative modeling consortium in which three groups develop natural history models of uterine cancer.
These models will incorporate known risk factors for uterine cancer and population level changes in the
prevalence of these risk factors over time. The models will include pathways for both favorable prognosis (type
I) uterine cancer as well as more aggressive (type II) neoplasms.
Once developed and validated, we will perform comparative modeling to examine issues of importance to
clinicians and policymakers. First, we will examine currently available and emerging strategies for screening
and prevention of uterine cancer in women. Second, we will examine the harms, benefits, and cost-
effectiveness of treatment strategies for uterine cancer including adjuvant therapy, treatment of metastatic
disease, and treatment of recurrent disease including immunotherapy. Third, we will estimate how changing
epidemiologic factors and social determinants of health influence racial disparities for uterine cancer. Fourth,
we will explore the impact of the rising rate of obesity on incidence and mortality of uterine cancer and develop
novel, web-based tools to determine how state-level obesity control activities influence incidence and mortality.
Finally, we will explore how the declining hysterectomy rate and changing patterns of care for gynecologic
diseases influence uterine cancer incidence and mortality. At the completion of this work, these data will be
widely disseminated to patients, providers, and policy makers and have the potential to significantly impact the
clinical care of women with uterine cancer and to guide cancer control strategies. Further, these models will
serve as an invaluable resource for the uterine cancer community as new clinical questions and challenges
emerge.

Public health relevance
The incidence and mortality of uterine cancer are rising dramatically in the U.S., especially among black. We will develop three natural history models of uterine to estimate the harms, benefits and cost-effectiveness of screening, prevention and treatment options for uterine cancer. We will likewise use these models to address areas of public health relevance including racial disparities, the growing obesity epidemic in the U.S., and changing rates of hysterectomy for benign gynecologic disease, all of which will have profound effects on the incidence and mortality of uterine cancer in the coming decades.